DEC VAX MODEL 8530 TO UPGRADE UWCCC COMPUTER SYSTEM

The University of Wisconsin Clinical Cancer Center (UWCCC) Biostatistics Program provides statistical and computational support for a large number of PHS research projects. The system is the major tool used for analysis of research data by not only the UWCCC but five other departments in the University of Wisconsin School of Medicine. Funds are requested to upgrade the current computer system to provide for additional computational power to meet the projected needs of these projects.